Physical Genomics and Engineering Training Program

PROJECT SUMMARY/ABSTRACT
The mission of the “Physical Genomics Predoctoral Training Program” (PGTP) is to train the next generation of
transdisciplinary scientists that will bridge molecular biology, bioengineering, physics, optics, chemistry, and
medicine. Through collaboration of program faculty in the McCormick School of Engineering and Applied
Sciences, the Feinberg School of Medicine and the Weinberg College of Arts and Sciences, the PGTP aims to
enable trainees to acquire and apply a broad skillset that addresses the physical manipulation of living systems
in the pursuit of new strategies for the treatment of disease.
Physical genomics is a new field that involves understanding the structure, function, and fundamental principles
of chromatin, an intricately folded group of macromolecules including DNA, RNA, and proteins that houses
genetic information within cells and determines which genes get suppressed or expressed. With this
understanding, researchers can reversibly regulate, control, and even reprogram global patterns of gene
expression without altering the genes themselves. This has wide implications in the treatment of diseases such
as cancer and Alzheimer’s and other potential applications such as improving crop yields and mitigating the
impact of climate change on plants and coral reefs.
The PGTP will deploy a range of strategies to help trainees integrate practical, hands-on experience with the
knowledge base required to advance research in physical genomics. Through an evidence-based approach to
training, trainees will participate in experiential learning and seminars focused on reprogramming chromatin to
treat disease and engineer living systems to overcome environmental challenges using breakthrough optical
imaging, computational genomics, and molecular biology. The trainees will be mentored by faculty with an
outstanding record of productivity and mentorship. Program mentors will provide ongoing review, evaluation, and
mentoring of trainees with the goal of creating a resilient, diverse cadre of scientific professionals.
The ability to regulate the physical structure of chromatin represents a new frontier in biological discovery and
has the potential to be one of the major drivers of 21st-century biotechnology. The PGTP aims to position its
trainees as the next generation of interdisciplinary biomedical leaders able to explore this frontier through an
exceptional training experience in physical genomics.

Public health relevance
PROJECT NARRITIVE The proposed Physical Genomics Predoctoral Training Program will support the transdisciplinary training in molecular biology, bioengineering, physics, optics, chemistry, and medicine with the goal of providing an understanding of systems and integrative biology in the context of the emerging field of physical genomics.